Screening for inhibitors of M. tuberculosis persistence-related lipid metabolism

DESCRIPTION (provided by applicant): Infection with Mycobacterium tuberculosis (Mtb) often results in a chronic tuberculosis (TB) infection. Of those infected, ~90% mount a successful immune response that sequesters the bacterium in a granuloma. The granuloma limits the spread and growth of the bacterium and results in a persistent infection. Under conditions that weaken the immune system Mtb can be released from the granuloma and establish an active, infectious disease state. Developing new therapies that target mechanisms required for Mtb to establish, maintain or exit a persistent state has the potential to shorten the course of current ~6-9 month Mtb drug regimens as well as combat the emergence of multidrug-resistant Mtb. Mtb alters its physiology in response to host immune pressures thus enabling the bacterium to remain viable in humans for decades. Mtb is an intracellular pathogen that resides within macrophages (M), a host immune cell that kills most other bacteria. Following infection, the M releases immune modulators that orchestrate the formation of a granuloma around the infected M. The granuloma limits the availability of nutrients and oxygen to the bacterium and drives Mtb to realign its gene expression and physiology to support a non-replicative, persistent (NRP) state. Transition into and maintenance of NRP is governed, in part, by the DosRST two component regulator system (TCS). DosR is a DNA binding response regulator that is phosphorylated by the sensor kinase DosT to induce expression of approximately 50 genes in response to cues such as hypoxia. One of the most strongly DosR induced genes is triacylglycerol synthase 1 (tgs1), which is responsible for the accumulation of intracellular triacylglycerol (TAG). In vitro growth conditions that induce DosR and NRP cause Mtb to accumulate inclusion bodies that are primarily composed of TAG. These TAG inclusion bodies are also observed during infections and in clinical sputum samples from infected humans, supporting a role for TAG accumulation in the progression of TB during chronic infection. We propose to exploit Mtb TAG metabolism pathways to develop high throughput screening (HTS) platforms that target Mtb persistence pathways. We will develop fluorescent reporter assays that measure TAG metabolism: i) directly by staining TAG inclusions with the fluorescent stains, or ii) indirectly by using a synthetic tgs1'::GFP reporter strain (Specific Aim 1). These HTS platforms will be optimized and validated in a 384 well format and the best performing platform will be used for a HTS of a 500,000 small compound library for inhibitors of TAG metabolism (Specific Aim 2). Hits identified in the screen will be validated, prioritized and the most promising compounds will undergo preclinical characterization including, mechanism of action, structure activity relationship studies, and efficacy in animal models of infection (Specific aim 3). The goa of this proposal is to identify a lead compound that is suitable for further optimization and that specifically targets the chronic stage of tuberculosis infection.

Public health relevance
PUBLIC HEALTH RELEVANCE: The spread of tuberculosis is a global health crisis leading to over one million deaths annually. The global burden of tuberculosis is a threat to the health of al Americans, and directly relevant to the mission of the National Institute of Allergy and Infectious Diseases, given the easy transmission of the disease through the air and the emergence of drug resistant strains that are difficult to treat. Moreover, there exists an increasing population of Americans with enhanced susceptibility to TB due to factors associated with compromised immune systems, including: HIV infection, the use of anti-rejection and anti-inflammatory drugs, as well as natural decreases in immunity associated with an aging population. __SpecificAimsTextDelimiter__ Specific Aims: Screening for inhibitors of M. tuberculosis persistence-related lipid metabolism Infection with Mycobacterium tuberculosis (Mtb) often results in chronic tuberculosis (TB). Of those infected, ~90% mount a successful immune response that sequesters the bacterium in a granuloma. The granuloma limits the spread and growth of the bacterium and results in a persistent infection. Under conditions that weaken the immune system, such as co-infection with HIV, malnutrition, use of immune-suppressive drugs, or old age, Mtb can be released from the granuloma and establish an active, infectious disease state. Developing new therapies that target mechanisms required for Mtb to establish, maintain or exit a persistent state has the potential to shorten the course of current ~6-9 month Mtb drug regimens as well as combat the emergence of multidrug-resistant Mtb. Mtb alters its physiology in response to host immune pressures thus enabling the bacterium to remain viable in humans for decades. Mtb is an intracellular pathogen that resides within macrophages (M ), a host immune cell that kills most other bacteria1. The M phagosome has access to nutrients via the recycling endosomal pathway and is an environment in which adapted bacteria can exist in a replicative, growing state1. Following infection, the M releases immune modulators that orchestrate the formation of a granuloma around the infected M 2. The granuloma limits the availability of nutrients and oxygen to the bacterium and drives Mtb to realign its gene expression and physiology to support a non-replicative persistent state. This transition between replicative growth and non-replicative persistence (NRP) is a widely studied facet of Mtb physiology because it is thought to play a key role in Mtb antibiotic sensitivity3,4, the establishment of chronic infections in humans5,6, and the reactivation of Mtb from a persistent state. Transition into and maintenance of NRP is governed, in part, by the DosRST two component regulator system (TCS). DosR is a DNA binding response regulator that is phosphorylated by the sensor kinases DosS and DosT to induce expression of approximately 50 genes in response to cues such as hypoxia, nitric oxide (NO) and carbon monoxide (CO)7-11. DosRST appears to play a role both during M infection where DosS senses phagosomal NO and CO, as well as during NRP where DosT senses the hypoxia of the granuloma10. One of the most strongly DosR induced genes is triacylglycerol synthase 1 (tgs1), which is responsible for the accumulation of intracellular triacylglycerol (TAG)12. in vitro growth conditions that induce NRP and DosR cause Mtb to accumulate lipid inclusion bodies that are primarily composed of TAG13. These TAG inclusion bodies are also observed during M infections and in clinical sputum samples from infected humans14,15. Because Mtb induces TAG accumulation in an NRP-, DosR-, and human infection-dependent manner, it is hypothesized that TAG accumulation plays an important role in the progression of a chronic TB infection. We propose to exploit Mtb TAG metabolism pathways to develop high throughput screening (HTS) platforms that target Mtb persistence pathways. We will develop fluorescent reporter assays that measure TAG metabolism: i) directly by staining TAG inclusions with a fluorescent stain, or ii) indirectly by using a synthetic tgs1'::GFP reporter strain (Specific Aim 1). These HTS platforms will be optimized and validated in a 384 well format and the best performing platform will be used for a HTS of a ~500,000 small compound library for inhibitors of TAG metabolism (Specific Aim 2). Hits identified in the screen will be validated, prioritized and the most promising compounds will undergo preclinical characterization including, mechanism of action, structure activity relationship studies, and efficacy in animal models of infection (Specific Aim 3). The goal of this proposal is to identify a lead compound that is suitable for further optimization and that specifically targets the chronic stage of tuberculosis infection. R21 Phase Specific Aim 1: Development of TAG metabolism fluorescent reporters that are optimized for HTS 1. Optimize the use of Nile Red stain to directly detect TAG lipid body accumulation. 2. Develop a synthetic Mtb tgs1'::GFP reporter that exhibits NRP-inducible fluorescence. Specific Aim 2: Perform a HTS for inhibitors of persistence-associated TAG metabolism 1. Screen a 500,000 small compound library for inhibitors of persistence-associated TAG metabolism. 2. Validate primary hits to identify compounds suitable for continued study. R33 Phase Specific Aim 3: Preclinical characterization of hits to identify a lead compound targeting persistence- associated TAG metabolism 1. Characterize function and mechanism of prioritized inhibitors of persistence-associated TAG metabolism. 2. Structure activity relationship and medicinal chemistry studies of prioritized compounds. 3. Determine efficacy of compounds in animal infection models.